UCLA Pulmonary and Critical Care Medicine Training Program

PROJECT SUMMARY/ABSTRACT
This is the renewal application for a multidisciplinary training program in Pulmonary and Critical Care Medicine
(PCCM) at the David Geffen School of Medicine (DGSOM) at UCLA. The training program will continue to
provide training in basic science and clinical research relevant to the study of PCCM-related diseases. The
program proposes to continue to support a total of six postdoctoral trainees (M.D.s, Ph.D.s and M.D./Ph.D.s) for
a two year experience in a highly structured environment under the close supervision of faculty mentors. The
trainees will take advantage of experienced faculty mentors whose research encompasses themes of the
following: 1) Infection/Inflammation/Transplantation, 2) Lung Carcinogenesis, 3) Health Services Research and
Prevention, 4) Biomedical Informatics, Systems Biology and Data Science and 5) Vascular Biology and Rare
Diseases. The program will continue to utilize faculty mentors from several Departments in the DGSOM, the
Fielding School of Public Health and the Henry Samueli School of Engineering and Applied Science at UCLA.
The faculty mentors have extensive research experience in diverse, yet overlapping areas of molecular and
cellular biology, immunology, psychiatry and biobehavioral sciences, internal medicine and health sciences,
health policy and management, biomedical, biostatistics and bioinformatics, cancer signaling and metabolism,
computer science, vascular biology and clinical study design. The faculty mentors have previously trained
postdoctoral trainees, who have subsequently gone on to independent and productive careers in academia or
industry. The environment at UCLA together with the faculty mentors will continue to offer an outstanding
experience for trainees in research disciplines relevant to PCCM-related diseases. The program will continue to
provide a structured curriculum that contains appropriate coursework, exposure to relevant lecture series and
an intensive basic science or clinical research experience. The training program has been highly successful in
developing new investigators with the majority of trainees continuing in research careers in academia or industry.

Public health relevance
PROJECT NARRATIVE Diseases related to pulmonary and critical care medicine (PCCM) remain among the leading causes of morbidity and mortality, nationally; however, recent advances in molecular and cellular biology, immunology, clinical intervention and biomedical informatics are unleashing the power of scientific discovery to impact health. The UCLA PCCM Training Program (PCCMTP) is dedicated to mentored, interdisciplinary team-based training of a new generation of academic and industry leaders in basic, translational and clinical research. By deploying facilities and resources of renowned multidisciplinary mentor faculty, we will fulfill the program mission of training a cadre of investigators who will discover novel underlying basic principles of PCCM-related diseases and translate these discoveries to improve health.